A randomized double-blind, placebo-controlled phase 2 clinical trial of intravenous citrulline for vaso-occlusive crisis in sickle cell disease

Project Abstract
Sickle cell disease is a genetic red blood cell disorder affecting approximately 100,000 individuals,
primarily of African descent, in the United States alone. The presence of abnormal hemoglobin (hemoglobin S)
leads to sickling of red blood cells and vaso-occlusion, resulting in acute episodes of pain. Acute pain, or “vaso-
occlusive crisis” (VOC), is the most frequent cause of emergency room visits and hospital admissions in sickle
cell disease, contributing to the high burden of health care costs for these patients. Opioids are the mainstay of
treatment for a VOC. However, treatment with opioids runs the risk of both short and long term side effects such
as itching, constipation, respiratory depression, opioid tolerance and addiction. Because of these often severe
consequences, alternative treatment modalities to opioid therapy are urgently needed in this high-risk population.
Nitric oxide, which is generated from the amino acid citrulline through the urea cycle, is a powerful vasodilator,
and low nitric oxide levels play an important role in the pathogenesis of vaso-occlusion. Citrulline plays an
important role in nitric oxide production in endothelial cells, and consequently may be able to ameliorate vaso-
occlusion. We hypothesize that the introduction of L-citrulline to standard (opioid) therapy will shorten hospital
length of stay and decrease opioid use. In this phase 2 clinical trial, patients with sickle cell disease will be
randomized to receive either the study drug (intravenous citrulline) or placebo to determine if citrulline
administration leads to improvements in pain and decreases in hospital length of stay. In addition, we will
evaluate how the body reacts to the study medication by measuring tissue oxygenation, nitric oxide levels etc.,
while closely monitoring for side effects. To better assess how this new treatment might be tailored to meet
individual needs, DNA will be collected to evaluate the link between genetic variation in the nitric oxide pathway
and response to treatment with citrulline. The novel therapeutic option of intravenous citrulline has the potential
to significantly decrease opioid use and improve clinical outcomes for hospitalized sickle cell patients suffering
from vaso-occlusive sickle cell pain crisis.

Public health relevance
Project Narrative Acute pain, brought on by vaso-occlusion, is the most frequent cause of hospital admission in sickle cell disease and greatly reduces overall health and social well-being. The amino acid citrulline increases nitric oxide, which has vasodilatory properties and the potential to relieve vaso-occlusion. In this clinical trial, we will investigate whether the addition of this novel treatment, intravenous L-citrulline, will significantly impact opioid use and clinical outcomes in this high risk population.